Defining the Roles of BRCA2 and RAD51 in PARPi Response

PROJECT SUMMARY
PARP inhibitors (PARPi) hold tremendous therapeutic potential because of their selectivity for cells lacking
functional BRCA1, BRCA2, and other homology-directed repair (HDR) genes. However, as with other targeted
therapies, resistance to PARPi frequently arises, underscoring the unmet need to elucidate how PARPi cause
cell death in BRCA mutant but not normal cells. Individual PARPi may act through distinct mechanisms, either
by “trapping” PARP-DNA complexes, or by inhibiting repair of single-stranded (ssDNA) nicks that are
subsequently converted to double-stranded breaks (DSBs). Moreover, patients may exhibit differential drug
sensitivity depending on the specific causative BRCA gene mutation. Defining this fundamental landscape will
be critical to better predict responders/non-responders as well as the durability of patient response to PARPi.
Historically, a detailed, mechanistic study of how mutations in BRCA2 influence genome integrity has been
hampered by the immense challenge of manipulating and purifying this large protein. Recently, we have
overcome these challenges, allowing us to leverage a combination of in vitro biochemical assays and cellular
assays to pinpoint how individual pathogenic or targeted mutations influence specific functionalities including:
DNA binding, replication fork protection, RAD51 nucleoprotein filament formation, and RAD51-mediated DNA
strand invasion. In addition to applying these techniques to interrogate the explicit biochemical function(s)
compromised by pathogenic BRCA2 mutations, we will assess sensitivity to PARPi with strong, intermediate,
or weak trapping activity (e.g. Talazoparib, Olaparib, and Veliparib, respectively). Lastly, we will investigate the
function(s) reconstituted by “reversion” mutations identified in patients with PARPi-resistant tumors, which may
independently identify functional attributes necessary for PARPi sensitivity. Our long-term goal is to unveil the
molecular consequences of PARPi treatment that necessitate processing by BRCA2, RAD51, and other HDR
proteins. Our central hypothesis is that by elucidating how BRCA2 and RAD51 mechanistically overcome
PARPi-mediated toxicity, we will provide the necessary framework to understand how PARPi resistance can
develop in patients. Our hypothesis is based on compelling preliminary data illustrating the specific functions
of BRCA2 and RAD51 in response to PARPi. Thus, our rationale, to reveal the mechanism(s) that underlie
PARPi-mediated toxicity, will vertically advance knowledge surrounding the HDR response to PARPi, and
ultimately, improve clinical management of BRCA patients. In aim 1, we will utilize patient derived BRCA2
reversion alleles in our isogenic human cell models to interrogate what specific function(s) have been
“reactivated” to promote resistance to PARPi. In aim 2, we will determine how BRCA2 and RAD51 catalyze
the removal or bypass of PARPi trapped lesions using purified proteins and relevant model DNA substrates
(reversed forks, gaps) in reconstituted biochemical assays. Our approach is innovative because of our unique
skill set and development of robust cell-based and biochemical functional assays to dissect HDR mechanisms
focused on BRCA2 and RAD51. Our objective in the current work will be to apply our HDR expertise to solve a
long-standing mystery in the PARPi field: to reveal how HDR proficient cells effectively survive treatment. The
results are anticipated to have a positive impact on the clinical management of HDR deficient tumors as
therapeutic resistance and relapse are critical barriers to the successful treatment of patients.

Public health relevance
Project Narrative: Poly(ADP)-ribose polymerase inhibitors (PARPi) exemplify a promising therapeutic strategy for the treatment of homology-repair deficient tumors. The proposed research is relevant to public health as elucidation of the cellular DNA repair mechanisms that respond to PARPi treatment will enable novel approaches to combat clinical issues of resistance and relapse. Successful completion of the proposed research will advance the NIH mission to improve human health by providing the framework for the development of new therapeutics for the treatment of BRCA and homology-repair deficient malignancies.